Cardiovascular Health and Inflammation: Intersectional Impact of Structural Racism, Structural Sexism, and Structural Classism

Poor cardiovascular health (CVH) causes cardiovascular diseases (CVDs), and there is growing
evidence
that inflammation links poor CVH to higher risk of CVD. In the United States, there are disparities
in CVH and levels of inflammatory biomarkers by race, gender, and socio-economic status. According
to the intersectionality theory, health inequities do not arise solely from individual social
identities (i.e., race, gender, and socio-economic status) but result from interrelations of
individual social identities and structural oppressions (structural racism, structural sexism, and
structural classism). To date, no study we are aware of has used an intersectional perspective to
investigate effects of structural oppressions, alongside individual social identities, on overall
CVH or on inflammation. We will use intersectional approaches to understand associations of
structural oppressions with CVH and inflammation in Black and White women and men of the REasons
for Geographic And Racial Differences in Stroke (REGARDS) cohort study. REGARDS is a longitudinal
study of 30,239 Black and White adults (45 and older) from 1,860 of 3,000 US counties. The proposed
aims are to: 1) determine the intersectional impact of structural racism, structural sexism, and
structural classism on CVH in Black and White men and women over 10 years; 2) Identify
intersectional associations of structural racism, structural sexism, and structural classism with
inflammatory biomarkers measured in Black and White men and women after 10 years. To complete these
aims, we will create composite indices of structural oppressions at the REGARDS baseline visit and
analyze their intersectional associations with longitudinal CVH data and 92 inflammatory biomarkers
measured in Visit 2 samples. Inflammatory biomarkers will be measured using targeted proteomics in
the VCCBH Study Design and Molecular Epidemiology Core (Core B). Results of this research may
inform future preventive measures and policies to address CVH inequities and advance knowledge on
the biological embodiment of structural oppressions.